Molecular control of beige fat heterogeneity

PROJECT SUMMARY
Emerging evidence illuminates the biological significance of beige fat, an inducible form of thermogenic fat cells,
in the regulation of metabolic health. The best-known stimulus of beige fat biogenesis is cold acclimation and
subsequent activation of the β3-adrenoceptor (β3-AR) signaling pathway; however, recent studies identified a
variety of external stimuli, such as tissue injury and intermittent fasting, that stimulate beige fat biogenesis
through β3-AR independent pathways. Furthermore, our recent study identified a previously uncharacterized
population of beige fat, referred to as glycolytic beige adipocytes (or g-beige fat), whose developmental
regulation and origin are distinct from β3-AR-induced beige fat.
These results lead us to hypothesize that beige fat is composed of developmentally diverse cell populations, and
that each population plays unique biological roles depending on the nature of external cues (e.g., cold vs. tissue
injury). A technical hurdle to test the hypothesis, however, is the lack of genetic tools that enable us to target
particular adipocyte progenitor populations. Thus, we employed single-cell RNA (scRNA) analysis and identified
two distinct adipocyte progenitor cells (APCs) that give rise to cold-induced beige adipocytes (CD81+ APCs) and
g-beige fat from a myogenic lineage (MyoD+ APCs). Accordingly, this proposal aims to test the above hypothesis
by determining the developmental regulation, molecular mechanisms, and biological function of beige adipocytes
stem from CD81+ APCs and MyoD+ APCs. Our contribution in this proposal is to provide a fundamental
understanding as to how heterogeneous beige adipocyte populations are regulated by physiological and
pathological cues, and how they contribute to the regulation of metabolic tissue homeostasis, such as fuel
oxidation, angiogenesis, innervation, tissue fibrosis, and inflammation.

Public health relevance
PROJECT NARRATIVE Emerging evidence suggests the existence of developmentally distinct populations of adipose cells; however, the mechanisms of the adipose cell heterogeneity remains poorly understood. Our recent studies identified two distinct progenitors that give rise to beige adipocytes following cold acclimation and tissue injury, respectively. The proposed research will provide a fundamental understanding as to how these beige adipocyte populations are regulated by external and hormonal cues, and how they contribute to the regulation of metabolic tissue homeostasis.